ACTIVATED HUMAN MONOCYTES--GROWTH FACTORS WHICH MAY FUNC

Amphiregulin (AR) was observed by immunohistochemistry in biopsies of human venous stasis ulcers.Because tissue macrophages involved in wound repair derive from circulating monocytes, this research project intended to examine monocyte-derived growth factors and cytokines in the wound healing process. Using differential RT-PCR to semi-quantitate AR mRNA, freshly isolated human monocytes expressed AR mRNA following treatment with either lipopolysaccaride or "platelet releasate" . While waiting for the cloning by Dr. Tarnuzer of an internal RNA template for a quantitative competitive RT-PCR assay for 5 ligands and 4 receptors of the EGF Family, the questions we addressed were adequate answered in March by Mograbi, et al (Eur. Cytokine Netw., 8: 73-81, 1997) Activated monocyte lines, as well as peripheral blood monocytes, were reported to undergo a dramatic increase in AR, HRG, and HB-EGF mRNA , without a concomitant increase in EGFR, erbB-2 or erbB-4 transcripts. This indicates a paracrine role for monocyte growth factors. Thus, work on this project in our lab has been stopped. Ligands (growth factors, cytokines, etc.) and their receptors represent a major aspect of new product development within the biotechnology industry. Several members of the EGF supergene family (for example EGF, TGF-a, HB-EGF, ERG-R, erbB-2) are currently products at the pre-IND or IND stage. Research in the Cellular Pathology Section of LCB, DCB, OTRR, CBER on Amphiregulin's participation in wound healing will contribute directly to its development as a pharmaceutical product, and will enhance the capacity of CBER to accomplish scientific-based regulation of wound healing products of the EGF family, as well as PDGF-BB, Activated Platelet Supernatatant, Topical, and TGF-b, all of which are under active development as topical wound healing biologics.